TRAINING IN MOLECULAR AND CELLULAR BIOLOGY

DESCRIPTION (provided by applicant): The proposal requests continued funding of the predoctoral Training Program in Molecular and Cellular Biology at the University of Washington and the Fred Hutchinson Cancer Research Center (UW/FHCRC). Trainees in the program are chosen by a rigorous selection process that picks the top graduate students from three interdisciplinary programs and nine departmental programs. The major goal of this program is to train students in cell and molecular biology during their graduate careers by exposing them to a wide range of research in this area. Students in the Training Program receive training beyond the standard graduate program through a monthly student presentation series that includes all of the trainees, an annual retreat that includes the trainees and their advisors, and through lectures and symposia supported by this grant This program plays an important role in training the next generation of scientists for academia and industry. The trainees have a strong record of success as shown by their publications in graduate school and the career choices they make after they leave graduate school.